Disease-homing light delivery by engineering bioluminescent immune cells for whole body precision photomedicine

PROJECT SUMMARY
Photodynamic therapy (PDT) offers unique mechanisms of cell death and is used to treat many cancers in the
clinic. The principal of phototherapy is that photoactive chemicals delivered to the disease site convert incident
photonic energy into local chemical toxicity, avoiding a systemic shock. PDT is agnostic to classical drug-
resistance pathways and does not cause critical co-morbidities, making it attractive as a monotherapy or as a
component of multi-modal therapy. However, a major criticism of PDT is the need for an external light source,
which limits the application of PDT to superficial lesions or those accessible by fiber optics. To overcome this,
a paradigm shift in the mechanism of light delivery for PDT has recently emerged: bioluminescence (BL)
mediated PDT (BL-PDT), wherein BL enzymes activate spectrally matched, co-localized photosensitizers (PS)
within the lesion, eliminating the need for an external light source. Although this overcomes a major hurdle,
current methods that leverage semiconductor nanoconstructs for BL enzyme delivery are limited in their ability
to localize to the disease. Here, we propose a novel method for BL enzyme delivery and BL-PDT: to
genetically engineer ultra-bright bioluminescent immune cells (UBLIs) and exploit their disease-homing
capabilities, like chemotaxis, to traffic to and accumulate in sites of disease. This approach eliminates the need
for complex and potentially toxic nanoconstructs as a component of drug delivery—only the BL substrate and
PS administration (both non-toxic compounds) will be required. Recently, we introduced precision
photomedicine using a targeted, activatable PS that exhibited cellular selectivity and reduced off-target toxicity
in a metastatic cancer model. We will pair the proposed novel light delivery platform with precision
photomedicine for maximal benefit. First, we will optimize the BL-PDT platform in 3D cancer–immune cell co-
cultures across biologically and clinically relevant parameter spaces informed by Monte Carlo simulations.
Then we will demonstrate the approach in vivo by intravenous injection of UBLIs into an in vivo xenograft
model of cancer metastases informed by in vitro results. These proof-of-concept studies will enable
comprehensive safety and efficacy studies in multiple disease models in future funding periods. Ultimately, we
envision clinical translation involving extraction and engineering of patient immune cells, similar to chimeric
antigen redirected (CAR) T cell therapy, followed by reinfusion and administration of photomedicine. This new
therapeutic paradigm has potential to benefit many diseases in cancer and beyond, which justifies the high-
risk, high-reward nature of the proposal.

Public health relevance
PROJECT NARRATIVE Photomedicine avoids traditional side effects of systemic chemotherapy, yet effective outcomes are dependent on direct irradiation from an external light source that limits the scope and the types of cancers that may be treated. This proposal develops a precision photomedicine platform that exploits natural disease-homing properties of the immune system to mediate bioluminescent-activated phototherapy, which will be evaluated in 3D cancer–immune co-culture and a mouse model of cancer metastases by paring with our tumor-targeted, activatable photoimmunotherapy platform. Successful, proof-of-concept studies will establish a new paradigm of systemic, whole-body phototherapy by enabling immune cell-based light delivery to deep and diffuse metastatic disease that would otherwise be impractical to treat using an external light source, thereby overcoming a major limitation of conventional phototherapy.